Air Pollution, Sleep-Disordered Breathing, and Biomarkers of Sudden Cardiac Death Risk in Resource-Limited Settings

ABSTRACT
Air pollution is a significant global public health challenge, particularly in low- and middle-income countries
(LMICs), where populations face substantial dual exposure to ambient and indoor air pollution, primarily from
biomass fuel combustion. Fine particulate matter ≤2.5 microns in diameter (PM2.5) is a major contributor to
morbidity and mortality. Previous studies have demonstrated associations between PM2.5 exposure, a higher
prevalence of sleep-disordered breathing (SDB), and increased autonomic dysfunction. However, most of these
studies have been conducted in high-income countries, limiting their applicability to resource-limited settings
where PM2.5 exposure is substantially higher. As a result, the interaction between PM2.5 exposure and SDB and
their effects of autonomic dysfunction remains poorly understood in LMICs. This knowledge gap is particularly
concerning given the downstream effects of autonomic instability, including heightened cardiac repolarization
lability which is a key risk factor for sudden cardiac death (SCD). The interplay between SDB-related intermittent
hypoxemia and elevated PM2.5 exposure may amplify cardiac risks, as reflected by the QT Variability Index
(QTVI), a validated electrocardiographic (ECG) biomarker of SCD. To address these critical gaps, this study has
two specific aims: (1) evaluate the association between elevated PM2.5 exposure and the prevalence of SDB,
defined as an apnea-hypopnea index (AHI) ≥5 events per hour, in a Ugandan cohort; and (2) investigate whether
elevated PM2.5 exposure is associated with ECG biomarkers of SCD, independent of SDB severity and other
cardiovascular risk factors, in the same cohort. This cross-sectional study leverages over a decade of
epidemiological research experience in urban and rural Uganda. To achieve these aims, the study will deploy
personal air pollution monitoring devices and home-based polysomnography, including single-lead ECG tracings,
to collect granular data on PM2.5 exposure, SDB severity, and ECG biomarkers (e.g., QTVI). We hypothesize
that elevated PM2.5 exposure will be associated with increased SDB prevalence and higher QTVI values through
a dose-dependent mechanism linking air pollution to heightened cardiac risk. By integrating rigorous statistical
modeling and sensitivity analyses, this research will provide critical insights into the interactions between poor
air quality, SDB, and cardiac repolarization lability. The findings will inform public health policies, guide the design
of targeted interventions to improve air quality, and mitigate risks for SCD in LMIC settings.

Public health relevance
NARRATIVE This proposal investigates the impact of elevated PM2.5 exposure on sleep-disordered breathing and cardiac repolarization lability, focusing on resource-limited settings. Using home-based polysomnography, which includes single-lead electrocardiography tracings, and personal air pollution monitoring in Uganda, we aim to uncover mechanisms linking air pollution to sleep disorder breathing and sudden cardiac death. These findings will inform interventions to mitigate cardiac risks in vulnerable populations.